CORE A - Administrative Core

Administrative Core Project Summary
The Administrative Core will oversee the efficient use of resources and the equitable utilization of the services provided by
the Cole Eye Institute Vision Research Core supported by this P30 Core grant for vision research. Dr. Bela Anand-Apte
will serve as the Module PI and work closely with Resource Core Module Directors to monitor the efficient utilization of
funds distributed from this award to the individual Core modules. The Executive Committee, comprising the administrative
module PI and Resource Core Module Directors, will review and monitor the progress and efficiency of each resource Core
module supported by this grant. This Core will establish a clear line of authority to resolve any conflicts or problems that
may arise that would alter the efficient use of the module services by participating investigators. An external advisory board
will meet every 2 years to review the activities supported by the Cole Eye Institute Vision Research Core and offer
suggestions for improvement. The leadership of this module will see that primary access to the Core modules will be for
NEI R01 funded investigators; that newly recruited investigators will be able to obtain data for new NEI R01 grant
submissions with help from the resource Core modules; that the resource Core modules will help foster collaborative
interactions between RO1-funded investigators and newly recruited investigators; that the resource Core modules will be
helpful in attracting investigators from other departments in the institution to collaborative research on the visual system;
and that the resource Core modules will be highly visible as an attractive departmental resource as we continue to expand
our research faculty.